Rapid and Quantitative Point Of Care Stool Assays For The Diagnosis And Monitoring Of Inflammatory Bowel Disease

Project Summary
Predict Health LLC. proposes to develop and commercialize rapid, quantitative Point Of Care (POC) lateral
flow tests for novel stool biomarkers, for the diagnosis and monitoring of inflammatory Bowel Disease. The
goal is for the Lateral Flow Tests system to deliver the performance of clinical grade laboratory analyzers in a
POC platform with cost and workflow that is routinely and widely used in primary care settings. Dr.Mohan's Lab
(Subaward Investigator, University of Houston) has identified three stool protein biomarkers using well-
characterized healthy control, ulcerative colitis and Crohn's disease patient's samples in an aptamer based
proteomic screen. Phase I will focus on the procurement and standardization of antibodies to be used in the
Lateral Flow Tests (LFT). Stool sample extraction will be optimized and prototype LFT will be manufactured.
LFT signal detection will be rendered portable and quantitative by adopting a POC device with multispectral
sensor in collaboration with ams, USA (www.ams.com). The prototype POC LFT device will be tested in a well-
characterized cohort of healthy control, ulcerative colitis and Crohn's disease patient's stool samples to
demonstrate its functionality. During Phase II the prototype LFT will be analytically validated for limit of
detection, precision, linearity and measuring range. Pre-defined validation and performance criteria will be
established in conformance with established laboratory and clinical standards. LFT reagents that pass
analytical validation and performance criteria will be transferred to contract manufacturing facilities for
production of commercial grade POC LFT stool assays. Clinical validation will be performed using stool
samples from cross sectional and longitudinal IBD cohorts and compared to the current yardstick, fecal
calprotectin, and evaluated for sensitivity, specificity, and test accuracy, to establish clinically actionalble
diagnostic algorithms. The analytical and clinical data will be submitted to FDA for 510 (K) for use as an in vitro
diagnostic device for diagnosing and monitoring IBD. The availability of quantitative POC LFT stool assays of
consistent quality and performance addresses a significant current limitation to establishing the clinical utility of
new biomarkers for IBD and implementing their use in medical practice.

Public health relevance
Project narrative The ultimate goal of the proposed research is the manufacture and sale of point of care stool assays by a US company (The Predict Health, LLC). The cost effective, easy to use, rapid, quantitative and widespread availability of high-quality stool biomarker testing kits to the healthcare community will allow their use in clinical testing for the diagnosis and monitoring of inflammatory bowel disease (IBD). Application of accurate new clinical tests in conjunction with clinical knowledge of the etiology IBD will lead to reduced morbidity and cost of care associated with this complex disorder affecting large numbers of adults and children.